Identification of treatment parameters that maximize language treatment efficacy for children. TALK Initiative supplement.

Project Summary
The broad, long-term objective of this supplement is to Tackle Acquisition of Language In Kids (TALK),
specifically, to better understand the developmental trajectory and needs of late-talkers. These are toddlers
who are not using as many words as they should before the age of three. Late talking is associated with a host
of later issues including poor academic outcomes. However, it is difficult to know which toddlers will grow to
have persistent challenges, and whose challenges will resolve. This limits both our understanding of late
talking and our ability to serve late talkers efficiently and effectively. Our first specific aim is to collect follow-
up data from 50 of the late talkers formerly enrolled in our study to see how many are impaired or at-risk in
terms of language, speech, reading, cognition, and educational outcomes months to years after our initial
assessments. We will also use data from our original study to see if there are any early indicators that
predict later outcomes, using CART analysis. We will use age-appropriate standardized measures that are
either diagnostic or descriptive, as well as collecting educational records. This will be a more comprehensive
examination of former late-talkers’ skills than is usually performed. Thus, we hope to have a more
comprehensive picture of what development looks like for late talkers. For our second specific aim, we plan to
collect qualitative data from family members of late talkers and the, now older, late-talkers to better
understand the functional and social effects of having a Late Talker in the family and the lived
experience of being a Late Talker. There is almost no work on the functional reality of parenting a late talker
or being a late talker. We need to understand how this diagnosis impacts daily life. We will co-create interview
questions with family members of late talkers in a focus group and use the questions to interview family
members and late-talkers themselves. An evidence-based picture drawing protocol will be used as part of the
interview process for the now-older late talkers. Data will be analyzed using thematic analysis. Finally, for our
third specific aim, we plan to create a sharing protocol so that researchers studying late talkers can
aggregate data to answer questions that require larger data sets than single labs can easily obtain. We
will include input from other researchers studying late-talking to ensure the protocol will be useful and
accessible.

Public health relevance
Project Narrative This project aims to find out how late talkers perform in the areas of language, speech, phonological awareness/reading, cognition, and educational achievement months to years after they completed a vocabulary treatment study. We will also interview now-older late talkers and their families to find out about what daily life is like as a late-talker. We will share our data online in a way that allows other researchers to add to it, all so we can understand more about late talking.